Bridging the gap between mutation & cellular effects: Defining the mechanisms of hypertrophic cardiomyopathy

Hypertrophic cardiomyopathy (HCM) affects more than 1 in 500 Americans with an extensive burden
of morbidity in the form of arrhythmia, heart failure, and sudden death. More than 25 years since the discovery
of the genetic underpinnings of HCM, we continue to have limited understanding of the primary effect of
genetic mutation on protein function and it is unclear how the genetic mutation leads to hypertrophic signaling
in cardiomyocytes. This lack of understanding limits the development of effective pharmacotherapy for HCM.
The objective of this proposal is to further advance the knowledge of how mutations affect sarcomere function
using biochemical and biophysical approach using purified protein and skinned fiber, as well as human
induced pluripotent stem cell derived cardiomyocytes (hiPSC-CM) as tools for disease modeling to assess the
triggers leading to hypertrophy. Given the findings from prior biochemical assessment of myosin heavy chain
mutation that cause HCM, it is hypothesized that HCM mutations result in gain of function in sarcomere by
increase in number of myosin heads available for cross-bridge formation (Na) through protein interaction and
activation state of myosin. It is further hypothesized that increase in Na result in energy imbalance in cells due
to increased ATP usage, leading to altered Ca2+ dynamics and mitochondrial dysfunction.
In this proposal, 3 mutations in regulatory light chain (RLC) of myosin that are linked to HCM are
chosen to test the above hypothesis further: E22K, R58Q and D166V. In addition, D94A mutation that is linked
to dilated cardiomyopathy (DCM) is also chosen to assess the effect of mutation that causes the opposite
cardiac phenotype for comparison. Aim 1 measures the impact of HCM mutations on myosin's folded state, by
assessing protein-protein interaction between the RLC and other sarcomere components (including myosin
binding protein C) using novel binding affinity assay. Aim 2 quantifies the effect of HCM mutations on RLC
using skinned myofiber from rabbit and purified recombinant human protein, with respect to myosin
activation state by measuring the kinetics of myosin using fluorescent ATP. Finally, Aim 3 defines the cellular
effect of RLC mutations using hiPSC-CM, by measuring cell mechanics, Ca2+ dynamics and mitochondrial
function. I will particularly focus on obtaining properly matured hiPSC-CM by rigorous structural assessment.
The current proposal is designed to gain further understanding of molecular pathogenesis of HCM from
protein level to myofiber level, focusing on myosin's structural change leading to altered activation state. It will
also link these biochemical findings to biomechanical property at the cellular level, and transcriptional
profiling will be performed to identify new gene targets involved in hypertrophic signaling pathway. The
proposal will also allow me to learn further skills in myofiber and hiPSC-CM as new platforms for performing
functional analysis of cardiomyopathy model systems. Moving forward, this proposal will be the basis of my
independent R01 grant using these innovative approaches.

Public health relevance
PROJECT NARRATIVE Hypertrophic cardiomyopathy (HCM) is the most frequently occurring genetic disease affecting more than 1 in 500 general populations, while the exact mechanism from mutation to cellular and tissue phenotype remains poorly understood. The goal of this project is to understand how HCM mutation in myosin alters activation status of protein, leading to functional changes in cells and myofibers, and triggers the secondary signaling pathway leading to hypertrophy. Understanding precise mechanism of the primary effect of mutation on protein function to the secondary cellular signaling event will provide improved understanding of early pathogenesis of HCM and lead to identification of targets for therapeutic intervention. !